REDS-IV-P - CENTER FOR TRANSFUSION LABORATORY STUDIES (CTLS), PHASE 1.

Blood safety implications and advancing testing for screening donors with HIV infection taking antiretroviral (ART) and pre-exposure prophylaxis (PrEP) therapies